Research Education Core

PROJECT SUMMARY (Research Education Core)
Historically, training programs have not prepared researchers to directly engage in rapid, iterative learning
within a health care system that promotes practice informed by evidence and evidence informed by practice.
Yet, embedding researchers within the walls, teams, and priorities of health systems encourages dialogue
between researchers, clinicians, and administrators, and increases the responsiveness of research to the
needs of practice without sacrificing scientific rigor. The LHS E-STaR of the North (LEaRN) Research
Education Core (REC) will develop scientists capable of strengthening the rigor and application of research
evidence and of improving the implementation of innovative practices in health care organizations. The LEaRN
REC will leverage and expand the infrastructure established under the Minnesota Learning Health System K12
Mentored Career Development Program (MN-LHS) to train a diverse group of LHS scientists who embed
themselves into health care operations and bring value to decision-making processes by conducting rigorous
research responsive to the needs of clinical practices and patients. The MN-LHS has been exceptionally
successful, training 14 LHS scientists (clinicians, clinician investigators, and doctoral-level scholars) from five
healthcare delivery systems and representing primary care, subspecialties, nursing, pharmacy, anthropology,
sociology, engineering, biostatistics, and epidemiology. Substantial institutional support will accelerate the
creation of a community of LHS scientists, ensure that the scientists are exposed to a wider range of questions
emerging from clinical practice, and offer diverse opportunities for authentic embeddedness. The LHS
scientists emerging from the LEaRN Center REC will be prepared to balance the demand for rapidly
generated, practical evidence with the rigors of peer-review and scientific standards, rapidly translating
research to improve clinical practice and patient outcomes. The overarching goals of the LEaRN REC are to
provide 1) tailored educational experiences that leverage an existing, robust educational infrastructure, 2) a
novel competency-based curricula, and 3) health system partners that will serve as learning “labs” for LHS
research, offering unrivaled expertise in training embedded clinical scientists using patient-centered LHS
philosophies and methods. The goals of the LEaRN REC will be achieved by pursuing three aims: leverage
and expand our MN-LHS program, identifying and educating a new generation of embedded LHS scholars for
independent research careers in patient-centered and community engaged research (Aim 1); enhance the
diversity of LHS scientists, their science, and their mentors (Aim 2); and cultivate engagement opportunities to
ensure the LEaRN REC is responsive to the needs of patients, communities, and health systems (Aim 3). The
LEaRN REC will address current gaps in LHS training by supporting research projects designed with system
leaders, patients, and community members. The REC will recruit and train a new generation of deeply
embedded, actively engaged scientists who can leverage state-of-the-art methods for rapid-cycle research to
improve health outcomes of our most vulnerable populations.